Interdisciplinary and Translational Research Training in NeuroHIV

ABSTRACT:
This competing renewal application provides a plan for the continuation and further development of the
“Interdisciplinary and Translational Research Training Program (ITRTP) in NeuroHIV” for predoctoral students
studying central nervous system (CNS) complications of HIV infection and related areas of research. This is a
joint program from two institutions, Temple University and Drexel University, located in close proximity in
Philadelphia, Pennsylvania. This program also integrates training activities and research resources available in
the Comprehensive Center for NeuroAIDS (CNAC) involving both Temple and Drexel University and a
relationship with the clinical research training programs in HIV and Neurovirology based in the Departments of
Medicine, Microbiology, and Neurology as well as other clinical and basic science departments and the Center
for AIDS Research (CFAR) at the University of Pennsylvania. Our ongoing program will continue to develop
our citywide interdisciplinary and translational research training program in NeuroHIV through shared
resources, joint seminars, workshops, symposia, invited speakers, as well as thesis mentoring and educational
activities available at both Temple and Drexel. The graduate curriculum at both institutions is designed to
provide a broad-based scientific foundation in biomedical sciences, including neuroscience, immunology,
microbiology, pharmacology and physiology. This curriculum includes responsible conduct of research,
scientific communication, statistics, as well as advanced courses with in-depth training in molecular and
cellular neurobiology, neuropathogenesis, and translational neuroscience. This program brings together
multiple biomedical basic science departments and integrates joint training activities at two neighboring
institutions (Temple and Drexel) with unique and long-standing relationships between investigators located at
the University of Pennsylvania positioned immediately adjacent to Drexel. Inclusion of access to clinical HIV
investigators in translational student research projects, as well as Temple/Drexel CNAC basic science and
clinical core facilities greatly enhances our training program with respect to its interdisciplinary nature. It also
exposes students to the interrelatedness of basic sciences and clinical perspectives focusing on HIV CNS
dysfunction, co-morbid conditions (i.e. aging, substance abuse, co-infecting pathogens, cancer), HIV vaccine
and prevention strategies, and novel neuroprotective and therapeutic strategies to treat and cure HIV infection
in the periphery and reservoirs including the brain. Our joint training program, together with our joint
infrastructural resources available through our CNAC, provides a strong, interactive, and highly successful
training environment in neurovirology and neuroHIV within the Philadelphia region. In order to support and
enhance our under-represented minority recruitment within this program we will continue to provide summer
laboratory training of medical students, and students in health professional programs including post-
baccalaureate students that would provide pathways for entry into our Ph.D. and M.D./Ph.D. training program
in NeuroHIV.

Public health relevance
Narrative: This application describes the continuation of a training program for interdisciplinary predoctoral research to support the development of the next generation of biomedical scientists, capable of addressing current and future challenges in diagnosis, treatment, prevention, and cure research related to the neurological complications of HIV infection and associated co-morbidities in the era of combination antiretroviral therapy. This application provides a plan to increase the training and recruitment of minority candidates to the program that will be necessary to assure increased diversity in the training program in order to increase the number future investigators from diverse backgrounds entering the field to address critical issues related to HIV- induced CNS disease and other diseases of health disparity in general.